LYMPHOKINE: HOST DEFENSE AGAINST RICKETTSIAE

Epidemic typhus is an acute human disease caused by the obligate intracellular bacterium, Rickettsia prowazekii. R. prowazekki has a predilection for growth within the endothelial cells and an ability to multiply within the macrophages of the host. The host has mechanisms for defending itself against infection because epidemic typhus in the absence of antibiotics is not uniformly fatal. However, these mechanisms have not been delineated. We first described a species-specific lymphokine that prevented the growth of rickettsiae in fibroblasts and macrophage-like cells and would cause cytotoxicity in infected macrophage-like cells. From our recent work we now know that the lymphokine responsible for these effects is interferon-gamma (IFN-Y). Our goals involve the in vitro characterization of the mechanisms by which growth inhibition and cytotoxicity occur and a definition of a non-IFN-Y factor which inhibits initial infection by: I. Characterization of the kinetics of IFN-Y and delineation of the antirickettsial role of type I interferons. II. Determination of the mechanism of inhibition of rickettsial growth by examining the structure and function of rickettsiae in IFN-Y-treated cells; testing of lysates of IFN-Y treated cells on the metabolism of isolated rickettsiae; analysis of the metabolite pools of IFN-Y-treated cells for constituents for which the rickettsiae are likely to be auxotrophic; and analysis of protein profiles in human cells that become antirickettsial by cocultivation with murine IFN-Y and murine fibroblasts. III. Identification of the non-IFN-Y factor responsible for the inhibition of the initial infection of lymphokine-treated cells by rickettsiae through the use of monoclonal anti-IFN-Y antibody and reconstitution experiments. IV. Exploitation of various existing cell lines and isolation of new mutant cells in order to analyze the mechanisms involved in the induction of the antirickettsial state. V. Characterization and differentiation of the mechanisms by which cytotoxicity occurs in macrophages, macrophage-like cells and fibroblasts. Attention will be given to macromolecular synthesis, phagocytosis, phospholipase A activity, induction of the oxidative burst, and interference by rickettsiae with the systems which protect cells from endogenous reactive oxygen intermediates.